Identification of Pathogenic T cells in Axial Spondyloarthritis

PROJECT SUMMARY
My career goal is to better understand systemic diseases in rheumatology by examining the mechanisms of
ocular inflammation and determining which mechanisms are specific to the eye and which are shared with other
organs, particularly the joint. This five-year proposal for a Mentored Clinical Scientist Research Career
Development Award will help me mature into a productive, independent academic investigator in the field of
ocular rheumatology. Advances in this area should complement the body of work in the field to allow for a more
comprehensive understanding of systemic autoimmune disorders.
Axial spondyloarthritis is strongly associated with HLA-B27 and has frequent extra-articular manifestations
such as anterior uveitis, an inflammatory ocular disease that can lead to cataract, glaucoma, and permanent
vision loss. While discrimination between pathogenic and bystander immune cells in rheumatologic diseases has
been challenging, the intrinsic immune privilege of the eye increases the enrichment for pathogenic cell types.
Therefore, studying ocular immune cells and the corresponding populations in the peripheral blood provides a
novel opportunity to understand both organ-specific and systemic mechanisms of disease pathogenesis.
Using single-cell RNA sequencing (scRNAseq) in three individuals, we have preliminarily identified two
subsets of CD8 T cells that collectively accounts for ~50% of all CD8 T cells within the eye during HLA-B27+
anterior uveitis. While both types of CD8 T cells share a transcriptional program, such as expression of the
surface receptor CD161, the antigen-specificity is distinct for each population. The first population is a
conventional polyclonal CD8 T cell population that recognizes viral antigens, among others, but is able to express
IL-17 and therefore have been termed Tc17 cells. In contrast, the second population is an unconventional T cell
population that predominantly uses a single T cell receptor gene segment that specifically recognizes metabolites
of riboflavin synthesis and are called mucosal-associated invariant T (MAIT) cells. Given the difference in
antigen-specificity, we hypothesize that these two CD8 T cell types serve redundant roles in an antigen-
independent mechanism of inflammation.
We propose to establish whether MAIT or Tc17 cells play a central role in HLA-B27+ anterior uveitis by using
scRNAseq and multidimensional flow cytometry to assess (1) whether one or both CD161+ CD8 T cell subtypes
are conserved in HLA-B27+ anterior uveitis, (2) what mechanisms of activate these cells within the eye, and (3)
whether one or both of these subsets are dysregulated in the circulation prior to entry into the eye. Through
successful completion of this research, undergoing the didactic training, and receiving guidance from a
multidisciplinary group of experts, I plan to launch my career as an independent translational researcher
investigating the ocular manifestations of rheumatologic diseases.

Public health relevance
PROJECT NARRATIVE Spondyloarthritis is a complex disease with a multitude of manifestations, spanning the joint, skin, gut, and eye. Given the inherent immune restrictions of the eye, we theorize that sampling the human eye during periods of ocular inflammation will enrich for pathogenic immune cells in spondyloarthritis, specifically T cells. We propose to use single-cell RNA sequencing to identify putative pathogenic T cells in the human eye and to assess whether dysregulation of these T cells track with disease activity in other anatomic sites.